EFFECT OF HALOTHANE ON HUMAN NATURAL KILLER CELL FUNCTION

The primary objective of this project is to determine the mechanism by which halothane inhibits human NK cell function. The results of these studies may have a direct bearing on immune processes that require NK cell activity, such as infections or tumor progression.